2020 Immunometabolism in Health and Disease GRC

Project Summary/Abstract The 2020 Gordon Research Conference (GRC) on Immunometabolism in Health and Disease, subtitled `Cellular metabolism in immunity: basic and translational', will be the inaugural GRC on the interface of cellular metabolism and immunity (or “immunometabolism”), a cutting-edge, emerging field in immunology. Recent studies indicate that cellular metabolism serves as both a fundamental mechanistic driver of and intervenable therapeutic target in infectious, allergic, and other immune-mediated diseases. The realization that metabolism is reprogrammed during the immune response and that bioenergetic and other metabolites are `repurposed' to modulate immune functions has led to a recent paradigm shift. As this young and interdisciplinary field accelerates, there is a critical need to convene experts and trainees alike. To this end, we are holding a meeting at Bryant University in Smithfield, Rhode Island from June 21–26, 2020. We are assembling international experts, both from academia and industry, on the role of cellular metabolism in the programming of myeloid and lymphoid immune cells in immunity and disease, and thus expect to foment productive, high-level discussions and collaborations, as well as significant interest among early-career investigators and trainees. Among the Specific Aims of our meeting are presentation of cutting-edge unpublished science, discussion and resolution of current controversies in the field, identification/prioritization of unmet needs in the field, stimulation of new collaborations, and provision of a comfortable and productive forum for trainees and early-stage investigations to learn and share their findings. The Co-Chairs, Drs. Michael Fessler and Hongbo Chi, in consultation with the Vice Chairs (Drs. Jeffrey Rathmell and Kathryn Moore) and other field leaders, have planned nine oral sessions to promote dialogue among established leaders in immunometabolism and emerging experts ranging from trainees to early-career scientists: Session 1 - Repurposing of Bioenergetics in Innate Immunity and Short Talks. Session 2 - Metabolic Programming of Lymphocyte Function. Session 3 - Trained Immunity, and Short Talks. Session 4 - Sterols in Immunity. Session 5 - Immunity and Microbiota as a Driver of Metabolic Disease. Session 6 - Immunometabolism of the Tumor Microenvironment. Session 7 - Metabolism in Host Defense, and Short Talks. Session 8 - Cell Fate in Immunometabolism. Session 9 - Emerging Opportunities for Intervening upon Immunometabolism in Disease. The speakers and discussion leaders are diverse and inclusive, including women (29%), early-stage investigators (16%), underrepresented minority groups (10%) and international experts from five countries outside the US. The focus of our conference directly meets the mission and goals of NIAID towards advancing intervenable insights into infectious, allergic, and immune-mediated diseases, and we are honored to invite members of NIAID administration as attendees. Our meeting agenda addresses diverse topics related to the crosstalk between immunity and metabolism in myeloid and lymphoid cells in immune- mediated diseases, including infection, allergy, autoimmunity, cancer, atherosclerosis, obesity, and diabetes.

Public health relevance
Project Narrative The inaugural 2020 Gordon Research Conference (GRC) on Immunometabolism in Health and Disease, subtitled `Cellular metabolism in immunity: basic and translational' has a highly interdisciplinary program that brings together international experts, early-stage investigators and trainees to discuss emerging concepts, approaches, and opportunities at the interface of cellular metabolism and innate and adaptive immunity. The research topics in our program have been carefully selected to address both mechanistic roles for cellular metabolism in myeloid and lymphoid cells, and therapeutic implications of these functions in a wide variety of immune-mediated diseases (e.g., infectious disease, allergy, autoimmunity, cancer, atherosclerosis, obesity, and diabetes). Moreover, our program aims to foster interactions between academia and industry, and to help seed and cultivate the next generation of scientists in this critical cross-disciplinary field.